KININ2018CLE

Project Summary Support is requested for a unique, international, multidisciplinary conference entitled KININ2018CLE organized by Alvin H. Schmaier, Keith R McCrae, Evi X. Stavrou, Marvin Nieman, Sadashiva S. Karnik, and Jackson T Wright of Case Western Reserve University (CWRU). This meeting will be held in Cleveland, Ohio on the CWRU campus from June 17th-­20th, 2018. The general topic of this meeting is relevant to the NHLBI mission since it celebrates the growth of knowledge in several components of the plasma contact, kallikrein-­kinin, and renin angiotensin systems and the translation of that knowledge into therapeutic targets for several cardiovascular diseases. The contact activation and plasma kallikrein-­kinin system have long been recognized to produce bradykinin and influence blood coagulation, inflammation, fibrinolysis, complement and the renin-­angiotensin systems. These systems consist of biologically active peptides (e.g. bradykinin, angiotensin II, angiotensin 1-­7), their G-­protein-­coupled receptors (angiotensin receptor 1 and 2, bradykinin receptor 1 and 2, and Mas), the enzymes that produce these biologic peptides [factor XIIa, plasma kallikrein, renin, angiotensin converting enzymes, prolycarboxypeptidase, neutral endopeptidase (neprilysin)], and its natural inhibitor C1 inhibitor. In recent years, the list of disorders that are managed by targeting members of these systems has extended from hypertension to heart failure, hereditary angioedema, and arterial thrombosis inhibition without risk of hemorrhage. This meeting is unique because it will bring together thought leaders in diverse fields to fill gaps in knowledge, to communicate ideas and build new associations, and to forge new collaborations in academia and industry. This conference grant (R13) application requests funds for travel awards for trainees (pre-­doctoral students, post-­doctoral students, instructors, or assistant professors) for conference registration, travel, and hotel. These international kinin conferences are held every three years in different locations. The last time it was held in the United States was in 2002 in Charleston, South Carolina. Since that time, a new generation of investigators has developed due to several discoveries: 1) all murine models of contact proteins influence thrombosis risk without bleeding;? 2) multiple novel targets have been used to reduce bradykinin formation in the management of hereditary angioedema;? 3) previously unappreciated biologic mechanisms for factor XII activation have been recognized;? and 4) neprilysin combined with angiotensin receptor 1 antagonist have been recognized as a potent combination of agents to treat heart failure. The research momentum in these fields has been extraordinary and drives the need for this inter-­disciplinary conference. The goals of KININ2018CLE are several fold: 1) Disseminate the research and clinical progress in kinin biology since the last meeting in the United States;? 2) Bring together the world’s best investigators in the field of kinins for sharing research and generation of new ideas to fill gaps in knowledge for future investigation;? 3) Encourage fertilization of cross-­discipline research to stimulate new ideas and unique research opportunities;? 4) Emphasize those areas where kinin science is now being translated into clinical use;? and 5) Inspire the next generation of junior investigators in this field to achieve that which their teachers and mentors were unable to accomplish. KININ2018CLE objectives are several-­fold: 1) Foster communication, sharing of ideas, and future collaborations among participants;? 2) Clarify unknowns in the fields and infuse new knowledge with re-­ interpretations of older information;? 3) Educate a new generation of investigators in these content areas;? 4) Support career development of new investigators in the field;? 5) Stimulate collaboration between academia and industry;? 6) Stimulate the pharmaceutical industry interest in new areas where there is potential for development of therapeutic targets. The success of KININ2018CLE will be measured by several evaluating tools: 1) We will evaluate each speaker for objectivity, quality, and lack of commercial bias in the presentation;? 2) An overall meeting evaluation will be performed at conference conclusion;? 3) A meeting report that will be published in Frontiers in Hematology;? 4) An on-­line symposium of each speaker’s presentation will be published in Frontiers in Hematology within 12 months of the conference;? 5) We will ascertain the number of abstract speakers who were junior (pre-­and post-­doctoral students, instructors assistant professors) in career development. In sum, this conference intends to bring together a wide number of investigators in kinin-­related biology to foster communication, collaboration, and growth of the field in young investigators and continued translation into therapies for a number of disorders relevant to the mission of NHLBI.

Public health relevance
Project Narrative: KININ2018CLE is an international conference hosted by University Hospitals Cleveland Medical Center and Case Western Reserve University on the kinin field to address critical gaps in knowledge, research challenges and opportunities, and promising new strategies for treatments of acute attacks of hereditary angioedema, prevent thrombosis without bleeding risk, and improve hypertension and heart failure management. These fields are reaching a maturity of understanding after decades of studies in basic science. New therapeutics in several disease states related to this content area and within the scope of the NHLBI have occurred as result. The objective of this meeting is to foster its continued growth by bringing senior and junior investigators in academia and industry together to fill gaps in understanding, communicate ideas and forge common area of interest, and to foster academia and industry collaborations.